Yale/NIDA Neuroproteomics Center

Overall Summary
We propose to continuously improve the Yale/NIDA Neuroproteomics Center that brings exceptionally
strong Yale programs in proteomics and signal transduction in the brain together with neuroscientists from 9
other universities across the U.S. to maintain a virtual national resource that will collaborate to identify adaptive
changes in protein signaling that occur in response to substances of abuse. Twenty-six faculty with established
records of highly innovative research into the molecular actions of psychoactive addictive drugs, as well as of
other basic aspects of neurobiology, will work together in a unique synergy with the Yale Keck Laboratory to
support the Center, whose theme is “Proteomics of Altered Signaling in Addiction”. The Center will use cutting
edge proteomic technologies to analyze neuronal signal transduction mechanisms and the adaptive changes in
these processes that occur in response to drugs of abuse. With Co-Directors Angus Nairn (Psychiatry) and
Ken Williams (Mol. Biophys. & Biochem.) in the Administrative Core, the Center includes Discovery Proteomics
(DPC) and Targeted Proteomics (TPC) Cores. Biophysical technologies from the DPC extend protein profiling
analyses into the functional domain while phosphoinositide and lipid dynamics analyses from the DPC
leverage proteome analyses to provide an increasingly systems level view. A Biostatistics and Bioinformatics
Core that includes high performance computing and the Bioinformatics Support Program in the Yale Medical
Library provides essential support that leverages the value of the proteomic technology cores. A Pilot
Research Projects Core is vital for cultivating strong mentoring relationships and training the next generation of
substance abuse researchers. Technology pilot grants continuously drive innovation within the Center.
Behavioral adaptations that accompany drug addiction are believed to result from short and long-term
adaptive changes in brain reward centers. Thus, exposure to drugs of abuse regulates intracellular signaling
processes that alter gene expression, protein translation, and protein post-translational modifications (PTMs).
Repeated exposure to drugs of abuse leads to stable alterations in these signaling systems that are critical for
the changes in brain chemistry and structure of the addicted brain. Center Investigators will study the actions of
cannabis, cocaine, nicotine, and opioids on these intracellular signaling pathways in brain reward areas and
work with Center Cores to enable proteomic analysis of the single types of neurons that define the circuits that
underlie the actions and addictive properties of these drugs of abuse. Data-independent and targeted mass
spectrometry approaches, together with next generation proximity labeling methods, will be used to analyze
the impact of addictive drugs on the neuroproteome and its PTMs in a cell type- and subcellular-specific
manner. Together the Center Cores will develop novel methods for deep integration of genomic,
transcriptomic, and proteomic data with brain region, cell type-specificity.

Public health relevance
Project Narrative Drugs of abuse usurp and modify communication between different types of neurons within defined circuits in the brain, resulting in stable changes in the expression and activities of proteins (the “neuroproteome”) required for normal neuronal function. Improving our understanding of how drugs of abuse alter the distinct neuroproteomes of the specific neuronal sub-types that define the circuits that underlie the actions and addictive properties of drugs of abuse will provide deeper insight into the molecular basis of drug addiction and thus help in the design of new and more effective therapeutic strategies.